Investigating the role of gut-derived extracellular vesicles in PTSD following TBI

Abstract
Veterans and the general public with traumatic brain injury (TBI) have a high risk of developing
posttraumatic stress disorder (PTSD) and other psychiatric disorders, such as anxiety and depression. The
pathophysiological basis that contributes to comorbid PTSD and other psychiatric disorders following TBI is not
yet understood, and there are currently few effective treatments for comorbid TBI/PTSD. Serotonergic
dysfunction and neuroinflammation are strongly associated with TBI and psychiatric disorders. Gut microbiota
dysfunction induces inflammation and affects tryptophan metabolism, a precursor of serotonin, which is
involved in serotonin biosynthesis. Studies conducted on patients with PTSD and other psychiatric disorders,
as well as mice exposed to experimental stress, have shown a high correlation between perturbation in gut
microbiota and mental disorders. TBI also induces gut microbiota dysbiosis. However, the cause-effect
relationship and the underlying mechanisms by which gut microbiota disruption following TBI impacts comorbid
PTSD and other psychiatric disorders are still largely unknown. Extracellular vesicles (EVs), small nanovesicles,
play a crucial role in cellular communication and carry various molecules. Bacterial EVs in the gut contain
bacterial genetic and biomaterials that are associated with virulence and considered causative agents in many
diseases, while EVs produced by select probiotics have great therapeutic potential. Our pilot data reveal that
administration of TBI-gut-EVs to gnotobiotic mice affects the expression of genes related to host serotonin
metabolites and neuroinflammation. In contrast, treatment of TBI animals with EVs derived from select probiotics
significantly increases host serotonin levels and alleviates psychiatric-like behavior. Based on our novel findings,
we hypothesize that the changes in gut microbiota-derived TBI-gut-EVs are involved in the regulation of
serotonergic neurons, neuroinflammation, and PTSD-like behavioral impairments following TBI. The successful
completion of this study will not only provide new insight into the pathogenesis of TBI, but also promote the
development of novel microbial-based therapy for preventing and/or treating comorbid TBI/PTSD, and potentially
other psychiatric disorders.

Public health relevance
Project Narrative Veterans and the general public who suffer from traumatic brain injury (TBI) are at a significantly higher risk of developing psychiatric disorders such as posttraumatic stress disorder (PTSD), anxiety, and depression. A growing body of evidence demonstrates that TBI can disrupt the balance of gut microbiota, leading to a condition known as gut microbiota dysbiosis, which is strongly associated with psychiatric disorders. The objective of this project is to investigate the role of extracellular vesicles (EVs) derived from gut microbiota dysbiosis induced by TBI in the pathophysiology of comorbid psychiatric-like behaviors as well as explore the therapeutic potential of beneficial bacterial EVs by targeting the serotonergic system and neuroinflammation in a preclinical model of TBI, which will not only provide novel insights into the molecular mechanisms underlying psychiatric complications following TBI but also have the potential to facilitate the development of microbial- based approaches for the prevention and treatment of TBI in patients.